Researching understudied proteins of Chiari Malformation

SUMMARY
Multiple chromodomain-helicase-DNA-binding (CHD) proteins have been implicated in rare diseases. While
CHD proteins are functionally known to be DNA helicases and chromatin remodeling factors that can regulate
transcription, insight into their structure and how it influences function remains sparse. Even AlphaFold2
models for these proteins have large regions of low confidence (over 60% of residues in CHD8 have pLDDT
scores less than 70). Our long-term goal is to understand the molecular features of these proteins and how
they impact Chiari Malformation such that better diagnostic and treatment approaches can be realized. The
primary goal of this proposal is to produce full-length wild type and disease related variants of three CHD
proteins on NIH’s list of understudied proteins related to rare disease and begin their biochemical and
structural characterization. Our hypothesis is that in vitro cell-free expression can overcome the primary
bottleneck to producing these proteins to begin deeper molecular characterization studies. The rationale
underlying the proposed work is that cell-free expression allows small scale, versatile and rapid optimization
of conditions to increase the chances of synthesizing a full-length protein that has similar solubility,
biochemical and other characteristics as the native protein. Two specific aims will be pursued to complete this
work: 1) Employ cell-free expression to synthesize CHD2, CHD7, and CHD8 as full-length wild-type proteins
along with 2 disease related variants of each. 2) Begin deep profiling of synthesized proteins by evaluating
protein-protein binding and DNA binding and initiate structural characterization. The success of the project
will hinge on recent innovations in our cell-free expression pipeline including the ability to perform both
functional binding and structural studies from cell-free expression reactions of only 25-microliter volume and
without purification. The proposed research is significant since it will reveal new molecular details
about 3 understudied proteins linked to multiple rare diseases. It will also lay the foundation for a workflow
extending our cell-free expression pipeline from bioenergy research and into the biomedical field to permit
its application toward other understudied proteins in the future. The expected outcome of this work is the
synthesis of wild type and mutant variants of CHD2, CHD7 and CHD8 along with initial biochemical and
structural characterization. Follow-on projects are expected to provide more in-depth molecular phenotyping.
The results will immediately impact the study of Chiari Malformation and advance the understanding of the
CHD family of proteins.

Public health relevance
NARRATIVE Our proposed research is relevant to public health and addresses NIH RFA-TR-22-030 for Investigating Understudied Proteins since we aim to generate an improved understanding of three chromodomain- helicase-DNA-binding (CHD) proteins that are understudied and implicated in multiple rare diseases including Chiari Malformation. We will use advanced cell-free expression techniques combined with microscale reaction volumes to generate functional wild type and disease related mutant CHD proteins. We will then begin structural characterization using cryo-Electron Microscopy and Native Mass Spectrometry to reveal their molecular similarities and differences that influence DNA binding and protein-protein interactions.